Mountain West Prevention Research Center

SUMMARY
The Mountain West Prevention Research Center (MW-PRC) will address the increasing inequities in childhood
obesity in lower income rural and micropolitan (<50,000 residents) communities in Idaho, Montana, Nevada,
Utah, and Wyoming. These communities experience a confluence of poverty, economic instability, high obesity
rates, food insecurity, and a lack of access to healthcare and existing evidence-based interventions. There is a
critical research and translational gap in the dissemination and implementation of evidence-based, family
healthy weight programs to address obesity in these communities. To date, our team has developed
successful strategies to address three key dissemination and implementation barriers to eliminating obesity-
related inequities in lower income rural and micropolitan communities. These include the development of the
Building Healthy Families (BHF) Online Training Resources and Program Package and Action Learning
Collaborative that addressed known barriers related to local implementation capacity, delivery by diverse
organizations, and access to relevant program materials. The goal of the MW-PRC is to eliminate income-
related inequities in childhood obesity by addressing a fourth key barrier—challenges in identifying,
enrolling, and retaining families in evidence-based family healthy weight programs. We will focus on increasing
access to and the reach of BHF, the only CDC-recognized family healthy weight program designed in, and by,
rural and micropolitan communities, using population health management (PHM) and community-based
participatory research methods. Our Center will utilize a Community Advisory Board representing state and
local health departments, community health centers, and other community-based organizations and aims to
build local academic and community capacity to conduct applied prevention research to resolve income and
geographic inequities in childhood obesity. The Core Research Project will include a type 3 hybrid
effectiveness implementation study using a sequential, multiple assignment, randomized trial design to
determine the impact of integrating PHM via text messaging and direct enrollment in BHF for lower income
families with a child (6-12 years) with obesity identified through community health center electronic health
record data. Furthermore, we will participate in the PRC Network to share translational resources for
disseminating and implementing family healthy weight programs to benefit low-income populations. The MW-
PRC will produce generalizable translational tools to move family healthy weight interventions into action in
rural and micropolitan communities and eliminate obesity-related inequities.

Public health relevance
NARRATIVE The Mountain West Prevention Research Center will produce generalizable translational tools to move family healthy weight interventions into action in rural and micropolitan communities and eliminate obesity-related inequities for lower income families. Core products will be packaged and made available for other communities to use, benefit from, and adapt. The multisector, coordinated partnership between community health centers and local organizations that can deliver family healthy weight interventions is a critical aspect of the approach that is scalable and can have a substantial impact across a wide variety of communities.